Identifying and exploiting therapeutic vulnerabilities of tumor-host interactions that drive bone-to-meninges breast cancer metastasis

Leptomeningeal (LM) metastases occur in a wide variety of hematologic and solid malignancies, including
leukemia, breast cancer (BC), and lung cancer. When LM metastases arise, they are almost always rapidly fatal,
causing severe neurologic symptoms and death within weeks to months. The molecular mechanisms that enable
LM metastasis have been poorly understood, and there are currently few targeted interventions to prevent or
treat this deadly disease complication. Our lab recently made the seminal discovery of a direct cell trafficking
pathway between the vertebral and calvarial bone marrow (BM) and the adjacent CNS LM. We initially
demonstrated this pathway in acute lymphoblastic leukemia (ALL) mouse models, showing that ALL cells invade
the central LM by migrating along the abluminal surface of emissary blood vessels that bridge the vertebral and
calvarial BM and subarachnoid spaces. These emissary blood vessels, whose basement membrane is highly
enriched in the extracellular matrix molecule laminin, pass from the BM through apertures in the vertebral or
calvarial bone to enter the LM. ALL cells crawl along the outside of this emissary vasculature by binding laminin
via cell surface integrin α6 laminin receptors, circumventing the blood brain barrier (BBB) to efficiently
metastasize to LM by this perivascular route. Subsequent work has shown that this direct cell trafficking pathway
between BM and LM is also used by immune cells to rapidly respond to CNS inflammation, although whether
this pathway is important for tumor-immune responses is unknown. It is also unknown whether continued tumor
integrin α6 interactions within the LM membranes, which highly express laminin, are important to sustain tumor
growth in the LM microenvironment. Our new data in mouse breast cancer (BC) LMD models show that
solid tumors can enter the LM through this novel BM-to-meninges perivascular migration pathway and
suggest that the high affinity laminin receptor, α6 integrin, is a critical target to prevent breast cancer
LMD. These data also demonstrate a crucial role for perivascular macrophages in promoting BC LMD.
Our proposal aims to further our understanding of the interplay between laminin-rich emissary vessels, meninges,
tumor cells, and immune cells in LM metastasis, in order to expose novel approaches to augment therapeutic
responses in the “sanctuary” of the LM. Through cutting-edge spatial transcriptomic analyses and real-time in
vivo imaging approaches, our work will also create an unprecedented understanding of the tumor
microenvironment of the LM niche, and how this laminin-rich environment contributes to disease survival and
proliferation. Finally, we will seek to translate these discoveries into clinical practice through an understanding of
how integrin α6 blockade can be used to prevent and treat LMD in preclinical models of BC LM metastasis. Our
approach represents a shift in the treatment paradigm for LMD, away from minimally effective cytotoxic therapies
toward molecularly targeted exploitation of microenvironment-based vulnerabilities.

Public health relevance
Cancer metastases to the leptomeninges (LM) are difficult to treat, create significant morbidity, and portend extremely poor survival. Our proposed work will define how malignant cells hijack developmental neuronal pathfinding mechanisms to enter the central nervous system and study how the innate and adaptive immune systems impact this metastatic pathway. Our studies will provide new mechanistic insight into a poorly understood biologic phenomenon and a therapeutic approach to an area of high unmet clinical need.